DESIGN OF SELECTIVE INHIBITORS OF DNA POLYMERASES

We are developing the synthesis of modified nucleoside polyphosphate. Fast atom bombardment mass spectrometry is required to confirm molecular weight of products and elucidate structures of byproducts.